Multimodal characterization of central nervous system inflammation in patients with aneurysmal subarachnoid hemorrhage

PROJECT SUMMARY/ABSTRACT
Aneurysmal subarachnoid hemorrhage (aSAH) is a devastating type of hemorrhagic stroke with high rates
of morbidity and mortality, and after initial stabilization, the mainstay of care is supportive. Early elevation of pro-
inflammatory cytokines in the central nervous system is associated with adverse outcomes after hemorrhage.
Whether time-to-resolution of this pro-inflammatory phase is a determinant of outcomes remains uncertain. The
goal of this research project and training plan is to provide Dr. Magid-Bernstein, an Assistant Professor of
Neurology at Yale University and a Physician-Scientist with expertise in immunology and neurocritical care with
the critical skills to become an independent investigator at the juncture of neuroimmunology and acute brain
injury. Her career development aims are: (1) to learn advanced statistical methods to analyze neuroimaging, (2)
to obtain expertise in advanced statistical techniques including analysis of large datasets and computational
transcriptomic analysis, (3) to gain skills in managing clinical research cohorts and clinical trial design, and (4)
to develop the leadership and academic skills to lead a research program. To achieve these goals, the PI has
assembled a mentorship team of experts in translational research in inflammation and stroke, neuroimaging, and
advanced biostatistical methods including transcriptomics.
Our preliminary data show that pro-inflammatory cytokines including interleukin-6, interleukin-8, C-C motif
chemokine ligand-2, and vascular endothelial growth factor are elevated in the cerebrospinal fluid (CSF) of
patients with aSAH within the first 3 days after ictus. The proposed study will investigate the duration of the pro-
inflammatory phase as a potentially modifiable determinant of outcome after hemorrhage.
Our central hypothesis is that failure to transition from a pro-inflammatory state to a reparative and anti-
inflammatory CSF profile in patients with aSAH will be associated with poor neurologic outcome, persistent
hydrocephalus, and inflammation on magnetic resonance imaging (MRI). We will test this hypothesis by
collecting serial CSF samples from 200 aSAH patients and measuring cytokines and numbers of immunologic
cells within the CSF to characterize the trajectory of inflammation over time and its relationship to outcome (Aim
1). We will investigate the relationship between this immune profile, persistent post-hemorrhagic hydrocephalus
on computed tomography (CT) images, and on vessel wall MRI (Aim 2). Finally, in an exploratory aim, we will
investigate the relationship between the above inflammatory CSF profiles, hydrocephalus on CT imaging,
inflammation on vessel wall MRI, and outcome (Aim 3). The proposed research is significant because no disease
modifying interventions exist for critically ill patients with aSAH, and identification of CSF and imaging markers
associated with poor outcome will enable development of targeted interventions to modify the course of this
devastating disease. This project is innovative because it will identify multimodal markers of neuroinflammation
after aSAH, paving the way for novel intervention.

Public health relevance
PROJECT NARRATIVE Aneurysmal subarachnoid hemorrhage is a type of hemorrhagic stroke caused by rupture of a cerebral artery aneurysm. The proposed project seeks to combine analysis of cerebrospinal fluid inflammatory markers and imaging evaluation of patients after aneurysmal subarachnoid hemorrhage to identify predictors of complications and outcome. Identification of patterns of inflammation associated with poor outcome will allow for future trials of targeted immunotherapeutics to prevent complications and improve outcome after aneurysmal subarachnoid hemorrhage.